Comprehensive Cancer Care Conference

[unreadable] DESCRIPTION (provided by applicant): The Comprehensive Cancer Care conference will be held on April 9-13, 2003 at the Washington Hilton Hotel in Washington, D.C. participants will include oncologists and other physicians, nurses, social workers and other conventional and complementary and alternative medicine (CAM) researchers and clinicians, cancer patients and their families. The primary objective of Comprehensive Cancer Care 2003 is to present research on the most promising and current complementary and alternative cancer therapies together with rigorous scientific evaluations of these therapies. Secondary objectives include 1) offering a sustained focus on the leading approaches to nutritional and herbal therapies in cancer treatment and prevention, (2) stimulating active participation of new researchers (3) providing systematic analyses of the scientific literature on complementary therapies; (4) engaging minority researchers, clinicians, and patient advocacy participation (5) presenting effective and promising models of integrative treatment for cancer; (6) providing the most up to date information on designing, developing, and finding funding for research on CAM therapies. The conference will consist of 2 days of pre-conference workshops with 6 concurrent workshops each day and three days consisting of 7 plenary sessions and 25 concurrent sessions which will be repeated. Topics to be covered in the pre-conference workshops include (1) Mind-Body Skills; (2) Nutrition and Cancer; (3) Writing an NIH Research Grant, (4) Ayurvedic Medicine; and (5) Herbal Therapies for Cancer. Topics to be covered in the plenary sessions include (1) Bringing CAM Therapies into the Mainstream; (2) Nutrition and Cancer; and (3) Integrative Cancer Care and Minorities. Categories of topics covered in the current sessions will determined by a call for abstracts but suggested topics include (1) Environmental Factors in Women's Cancers; and (2) New Research on Nutritional, Herbal, and Mind-body Therapies. Concurrent sessions will also include 6 Core Curriculum sessions and sessions on Research and Funding. [unreadable] [unreadable] [unreadable]